The Role of VTA GABAergic Neurons in Nicotine Addiction

DESCRIPTION (provided by applicant): Every year, tobacco use is attributed to approximately 400,000 deaths in the United States. Withdrawal from nicotine elicits aversive symptoms that interfere with normal behavior and prevent many smokers from quitting. Nicotine, the psychoactive compound in tobacco is known to act upon the major brain reward circuit, the mesocorticolimbic pathway. With other drugs of abuse, the activity of the inhibitory GABAergic neurons of the Ventral Tegmental Area (VTA) is altered. Nicotinic acetylcholine receptors (nAChRs) are upregulated in VTA GABAergic neurons with chronic nicotine use, specifically nAChRs containing both the α4 and β2 nAChR subunits. However, little is known regarding how increased expression of nAChRs on GABAergic neurons contributes to nicotine dependence. Utilizing a viral mediated, cell specific gene expression system to selectively express nicotine hypersensitive α4 subunit-containing nAChRs in GABAergic VTA neurons, I propose to elucidate the role of VTA GABAergic neurons in nicotine withdrawal. In Aim 1, I will test the hypothesis that chronic activation/desensitization of α4 nAChRs in VTA GABAergic neurons is sufficient to elicit withdrawal symptoms upon nicotine cessation. In Aim 2, using biophysical approaches, I will investigate the mechanism by which chronic treatment of and withdrawal from nicotine modulates GABAergic neuronal activity. The results from these experiments will provide a better understanding of the cellular components involved in nicotine dependence, and provide insight into developing more focused nicotine cessation therapies.

Public health relevance
PUBLIC HEALTH RELEVANCE: The use of tobacco is the number one preventable cause of death in the Western world. Although not the primary cause of death, nicotine, the addictive substance in tobacco, reinforces continual and unstoppable use. This project aims to understand the molecular and cellular interactions in neurons and between neuronal subpopulations in behaviors of nicotine dependence. The results gained from this project will hopefully be used to formulate new therapies for smoking cessation. !